A prospective clinical trial of immunosuppression reduction in recipients of low eplet mismatched renal allografts: the kidney for life initiative

PROJECT SUMMARY
Kidney transplantation is the best available treatment for end stage renal disease as it improves both survival
and quality of life and is more cost effective than dialysis. However, the lifespan of transplanted kidneys is
shortened due to chronic immune-driven injury and the direct nephrotoxicity of immunosuppressive drugs.
Premature graft loss and the need for re-transplantation worsens an already dire organ shortage. Prolonging
graft survival may hinge on optimizing immunologic matching of donors with recipients, to minimize targets of
immunologic attack and decrease the need for aggressive immunosuppression. HLA matching has historically
relied upon comparison of donor and recipient HLA genotypes determined either by serologic analysis or two-
dimensional gene sequences. With newer high-resolution genotyping, the physical structures of HLA antigens
can be predicted, enabling comparisons of donor/recipient HLA genotypes at the molecular level. In brief, with
high-resolution genotype data, a computer algorithm called HLAMatchmaker can distill gene sequences into
strings of polymorphic amino acids termed ‘eplets’ that are located on the HLA molecule surface and are thus
accessible to the host immune system. When donor and recipient HLA genotypes are translated into their
corresponding eplets, we can tally the immunologically recognizable differences between them as the number
of eplet mismatches. Retrospective data indicate that patients who, by chance, received deceaseddonorkidneys
with a low eplet mismatch (MM) load have lower rates of de novo donor specific antibody (dnDSA) formation,
superior graft survival, and may require less immunosuppression. With living donation, there is opportunity to
evaluate multiple potential donors for a given recipient and compare their degree of eplet MM before choosing
which donor to proceed with to transplant. Thus, living donor kidney transplant (LKDT) recipients are the optimal
patient population in which to test whether optimizing eplet matching indeed yields transplants that are at lower
alloimmune risk. In collaboration with the largest paired kidney exchange, the National Kidney Registry (NKR),
we have begun combining eplet MM analysis with its existing donor-recipient matching algorithms in order to
generate high volumes of low eplet MM living donor kidney transplants. These transplants are now being
performed at centers across the country as part of this pilot program. Preliminary data indicate that dnDSA
formation is rare occurred in these recipients, however the degree to which low eplet MM LDKT permits
immunosuppression reduction is not known. This R34 grant will enable us to design a multi-center randomized
trial to prospectively test immunosuppression reduction in recipients of low eplet MM LDKT, as well as to
compare the safety and efficacy of low eplet MM LKDT to high eplet MM LDKT. If our hypothesis is correct, we
will establish a pathway by which donor/recipient matching can be optimized to maximize graft longevity and
ultimately improve both patient survival and quality of life.

Public health relevance
PROJECT NARRATIVE Retrospective studies suggest that recipients of low eplet mismatch deceased donor kidney transplants have lower rates of de novo donor specific antibody formation, improved graft survival, and can tolerate lower than average levels of immunosuppression. Through our existing collaboration with the National Kidney Registry (NKR) we are currently utilizing eplet matching to generate high volumes of living donor/recipient pairings with low eplet mismatches. This R34 grant will enable us to design and conduct a prospective clinical trial of immunosuppression reduction in recipients of low eplet mismatch kidneys, to test the hypothesis that combining low eplet mismatch transplants with reduced immunosuppression is safe, effective, and leads to superior graft and patient survival, and greater quality of life.